Loaded Fibrin-Specific Nanogels for Sepsis-Induced DIC

PROJECT SUMMARY
Disseminated intravascular coagulation (DIC) is the pathophysiologic response to injury that leads to the
formation of microthrombi and subsequent activation of fibrinolysis. DIC is characterized by the consumption of
platelets, fibrinogen, and clotting factors, and it can present clinically with prothrombotic and/or hemorrhagic
phenotypes. DIC is most commonly caused by sepsis but can also be caused by trauma, cancer, pregnancy, or
severe organ injury. The treatment approach for DIC involves addressing the underlying cause, but the
contradictory nature of the disorder makes identifying an effective treatment protocol challenging, which is
reflected in the high mortality rate (50%) for humans with sepsis-induced DIC. DIC does not only affect humans
however, and the mortality for dogs with DIC is even higher at 62.5%. The benefits of anticoagulants and
fibrinolytics are still being studied but have been associated with an increased risk of off-target bleeding. We
have developed fibrin-specific nanogels (FSNs), which we have used in vivo to site-specifically deliver anti-
clotting drugs while also enhancing fibrin cross-linking and clot formation. Preliminary data have shown that
anticoagulant- or fibrinolytic-loaded FSNs address both DIC phenotypes by targeting and dissolving existing
clots, while simultaneously promoting clotting at sites of bleeding. Notably, the drug-loaded FSNs improve
hemostasis within only thirty minutes. When dual-loaded with both fibrinolytic tissue plasminogen activator (tPA)
and anticoagulant antithrombin-3 (AT3), FSNs have the potential to provide an enhanced effect by acting on two
different mechanisms. The objective of this proposal is to establish anticoagulant- and fibrinolytic-loaded FSNs
as safe and effective adjuvant therapies for sepsis-induced DIC and to further understand the mechanisms by
which loaded FSNs rapidly improve DIC outcomes. It is expected that dual-loaded FSNs will result in better DIC
outcomes than tPA and AT3 administered systemically or individually in FSNs by interacting directly with
neutrophils to recover platelet count and reduce hemorrhage. Aim 1 will optimize FSN drug-loading by examining
different loading doses of tPA and AT3 in FSNs and assessing their stability, loading efficiencies, release profiles,
and clotting and fibrinolytic abilities. Aim 2 will optimize the dose of loaded FSNs in vivo by examining
biodistribution, coagulation, microthrombi development, and side effects. Aim 3 will assess the role of neutrophils
in rapidly rescuing platelet counts with in vitro and in vivo models treated with drug-loaded FSNs. The successful
completion of these aims will identify the pathophysiology behind targeted tPA and AT3 treatment and provide
the framework for moving this novel DIC therapy into clinical trials. This proposal and associated mentorship
team will provide training critical for the applicant’s development as an independent clinician-scientist developing
drug delivery platforms for cardiovascular diseases that affect both humans and animals. The training
environment at North Carolina State University is ideal for the applicant’s interdisciplinary training goals, as the
applicant also has access to resources and opportunities at Duke University and UNC-Chapel Hill.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the current management protocols for disseminated intravascular coagulation (DIC) focus on the underlying disease, rather than addressing coagulopathy, and result in staggeringly high mortality rates for both humans and animals. We have developed fibrin-specific nanogels (FSNs) that site-specifically deliver anti-clotting drugs while also enhancing fibrin cross-linking and formation, providing a solution for both the prothrombotic and hemorrhagic DIC phenotypes. Loading FSNs with both a fibrinolytic and an anticoagulant has the potential to provide an enhanced effect on improving DIC outcomes, with the potential of overcoming the limitations of current therapies and saving lives.